Midbrain opioid circuit dynamics in pain and endogenous analgesia

PROJECT SUMMARY/ABSTRACT
Pain represents our ability to detect noxious stimuli in the environment and engage in behaviors to reduce
harm. This potentially life-saving function of pain can be disturbed by injury or illness leading to chronic pain that
exceeds its biological utility. Chronic pain inflicts long-term suffering and is a common clinical problem that chal-
lenges our health services and impairs the lives of millions in the United States. Although prescribed opioids
remain an important option for the management of pain symptoms, their use presents substantial risk for abuse
and overdose. Mu opioid receptors (MOR) in the brain are a crucial substrate for the analgesic action of exoge-
nous opioid drugs, however, our understanding of the endogenous opioid system on which these drugs act
remains incomplete and difficult to access. The discovery that the endogenous opioid system is recruited by
placebo analgesia – expectation that a treatment or context is pain-relieving even when it is not – stands to vastly
improve knowledge of pain-relevant opioid signaling mechanisms when applied to preclinical model systems.
My previous postdoctoral work demonstrates that placebo analgesia can be achieved in an operant conditioning
paradigm in rodents, which results in the suppression of nociceptive activity within MOR neurons in the ven-
trolateral periaqueductal gray (vlPAG), indicating recruitment of opioid peptide release and antinociceptive sig-
naling. This career development proposal aims to reveal, at the cellular and neural circuit levels, how the endog-
enous opioid system is activated by pain and placebo analgesic behavioral states in two key midbrain structures,
the vlPAG and ventral tegmental area (VTA) that have been implicated in pain processes and opioid drug func-
tion. Training in advanced imaging technologies and rigorous opioid pharmacology, combined with mentoring/ad-
visory team meetings and professional/career development activities will prepare me to completely attain and
succeed in an independent faculty position. In Aim 1 (K99 phase), I will use two in vivo approaches, one-photon
in vivo miniature endoscope (miniscope) calcium imaging for cellular resolution recordings of neural activity and
optogenetic neurocircuit manipulation, to delineate the signaling dynamics and function of the enkephalinergic
neural populations in the vlPAG in pain and placebo analgesia. Importantly, the vlPAG does not modulate pain
in isolation, but sends pain-relevant signals to affective-motivational regions like the VTA. Therefore, in Aim 2
(R00 phase), I will investigate the functional relationship between the vlPAG MOR-expressing neural population
and the VTA through optogenetics and miniscope recordings of VTA neural activity, to understand the role and
dynamics of these connected circuits across pain states. The results of these studies will produce fundamental
knowledge about the brain’s endogenous opioid system that can be applied to the development of future chronic
pain therapies that are safe and efficacious. Completion of this mentored career development plan will advance
my scientific skills and professional growth and lay the foundation for my independent research career.

Public health relevance
PROJECT NARRATIVE Opioid use disorder and overdose are pressing public health challenges that are exacerbated by an overreliance on opioid analgesics for the treatment of pain. Opioid analgesics lessen pain processes by engaging the endogenous opioid receptor system in midbrain areas such as the ventrolateral periaqueductal gray and ventral tegmental area, but also promote drug seeking by acting in these same regions. Therefore, the overall goal of this mentored career development proposal is to discern the fundamental role of midbrain opioidergic neural systems in pain and analgesia to inform development of future precision pain therapies that lack the dangerous and damaging effects of pharmacological opioid drugs.